Parsing the Interplay Between Biophysical and Biochemical Microenvironment Cues On Endometriosis Lesion Phenotypes Using Microphysiological Systems

Project Summary: Center for Engineering Endometriosis Care (CEEC)
The high prevalence, diversity of morphological and symptomatic presentations, array of potential etiological
explanations, and variable response to existing interventions suggest that different subgroups of
endometriosis patients with mechanistic bases of disease may exist. These factors, combined with the weak
links to genetic predisposition, make the entire spectrum of the human condition challenging to model in
animals. The majority of endometriosis research approaches questions as "diseased" or "control", with
stratification among clinical status of patients according to ASRM stages. The overarching goal the CEEC is to
reframe the way the clinical and basic science researchers together approach the complex landscape
of endometriosis: first, by creating a new framework for defining clinical cohorts, based on presumed distinct
biological mechanisms among different patient groups, for corresponding basic science studies; and second,
by developing and implementing new computational systems biology, tissue engineering, and organ-on-chip
models designed to address specific scientific questions arising from the mechanistic groupings of patients.
The average age of patients in published studies on endometriosis is above 30 - more than twice the
age of onset for many patients. Endocrine, metabolic, and immune systems are, on average, very different in
16 and 32 year olds; the physiology of lesions very likely is, also. We know little about the interplay between
systemic host factors and the drugs we now use to treat lesions on the physiology of the lesions. Why is the
disease invasive in some patients, and not others? Here, we propose to classify patient cohorts into 4 distinct
subgroups that differ by systemic physiology {ages 16-21 and ages 32-42) and lesion physiology {superficial
only, persistent; or invasive +/- superficial). This scheme allows us to construct an engineering landscape of in
vitro lesion microenvironments, according to the features of the lesion physical microenvironment and systemic
microenvironment, and a corresponding parameter space in which the magnitudes of cues are varied. Three
projects allow us to develop correlations between patient clinical phenotypes and in vitro models::
Project 1: Parsing Effects of Donor Source and Lesion Microenvironment on Lesion Phenotypes in Vitro
Project 2: Dissecting macrophage signal integration and function in endometriosis
Project 3: Correlates of a holistic in vivo cellular and molecular signature with clinical phenotypes
These projects will draw from a Biospecimen Coordinating Core. At the completion of this work, we will have
new tools, new insights into how existing hormone therapies work in patients, and hopefully a new language for
communication between clinicians and basic scientists in the trenches of endometriosis research. We will also
have a substantial impact on education of the next generation of endometriosis researchers, and patient
awareness of research efforts, through the activities of the education and outreach program.

Public health relevance
Center for Engineering Endometriosis Care This project seeks to reframe how clinicians, scientists, and patients work together to understand the complexity of endometriosis, by more carefully measuring features of the patient experience, and using patient tissues to build models of disease that are specific for each patient. These models will be used to test why current drugs fail in patients, and to identify targets for new drugs, to improve options for patients who are in pain and are infertile.